System on Chip for Intraoperative OCT

PROJECT SUMMARY
Intraoperative ophthalmic visualization saves the vision of tens of millions of people annually. A large portion of
surgical interventions requires manipulation of fine and sensitive layered tissue structures with micrometer-level
thickness that cannot be directly visualized with standard microscopy. Intraoperative Optical Coherence
Tomography (OCT) is an established imaging technology in ophthalmic clinics. Despite strong clinical indications
about the benefits of intraoperative OCT, common implementations of intraoperative OCT cannot provide the
performance required for intraoperative applications. All commercial implementations are based on Spectral-
Domain OCT, a technology that has limitations on the imaging depth and speed and on its ability to image moving
tissue. While Swept-Source OCT does not suffer from any of these limitations, its integration in the operating
room has been limited by technology readiness challenges. Recent progress on optics and algorithms for
SSOCT has highlighted a new potential to translate high-performance versions of the technology to the operating
rooms. High-speed and long-range lasers are now available commercially, and image analyses with artificial
intelligence are more advanced and faster to develop. Progress on the optics and algorithms fronts put extra
demand on the performance of the system's electronics that cannot be met using today’s architectures. To
provide the required OCT imaging needs where large volumes are scanned in real-time to cover the dynamically
changing operating zone, it is imperative to rethink the electronic architecture in modern ways with a completely
new approach. To achieve this goal, we are developing a novel electronics board that does not follow the
traditional architecture based on discrete components communicating via buses and hand-shacking protocols.
The board we are developing in this project is based on a Radio-Frequency System-on-Chip (RFSoC). This
architecture will enable real-time OCT volume imaging with 3x improvement in axial resolution, 4x in field of view,
and more than 10x in latency or the state-of-the-art research and development efforts in this field. The board we
are developing provides a versatile, unique, and highly-configurable solution for intraoperative SSOCT systems
at competitive cost, space, and power requirements. The development will offer a unique integration of features
needed for systems with virtually zero latency requirements.

Public health relevance
Project Narrative In the United States, eye surgeries are the most frequently performed surgical interventions aimed at mitigating the adverse effects of vision loss that can significantly impact the quality of life of individuals and their families, and pose serious safety risks, necessitating long-term care. Effective ophthalmic intraoperative visualization is crucial for achieving favorable surgical outcomes in the treatment of eye diseases. To enhance visualization and consequently improve surgical outcomes, we are developing a System on Chip to enable Swept-Source Optical Coherence Tomography to provide real-time 3- dimensional imaging with high-resolution, high-speed, low-latency, and the capacity to handle large volume scans.